Neuroimaging Training Program

Project Summary/Abstract
Productivity in basic and clinical neuroscience research is accelerating due to technological
advances in the area of biomedical imaging. These new technologies have the potential to
advance knowledge about the underlying etiology of brain-based disorders, mechanisms of
treatment, and predictors of response. This competing renewal grant proposal describes a
Neuroimaging Training Program (NTP) established in 2003 within the framework of the
longstanding and highly successful doctoral degree program offered by the Harvard-MIT
Program in Health Sciences and Technology (HST). HST is an ideal home for the NTP. The
sponsoring institutions, MIT and Harvard, and the affiliated teaching hospitals, have been and
continue to be at the forefront of the development and application of biomedical imaging
technologies. The faculty has consistently mentored leaders in the fields of biomedical imaging
and clinical translational imaging neuroscience. The goal of the NTP is to increase the number
of exceptional, interdisciplinary research scientists and engineers who are trained at the
interface of biomedical imaging technology, neuroscience, and clinical application to fill the
needs of academia, industry, and government.
In the past four funding cycles, the NTP developed a comprehensive core curriculum and
became established as an exceptional program for those wishing to pursue advanced training in
neuroimaging. The unique strengths of the NTP include in-depth, direct clinical training, a
comprehensive didactic curriculum specifically geared to this cadre of students, and vast
faculty and technology resources. Our outstanding faculty exemplify the highest standards in
teaching, advising, and mentoring. Each member of the faculty prioritizes their students' needs
to explore, identify, and achieve their career aspirations. Not focused on any particular niche of
neuropsychiatric disease (e.g., alcoholism or brain injury), or specific imaging modality or
approach, the NTP also prides itself on its multimodal approach to training and demonstrated
record of training students in a diverse array of technologies and their basic and clinical
applications. Funding is requested to support 6 pre-doctoral students each year, providing 2
years of funding per student.

Public health relevance
Project Narrative Investment in training of biomedical engineers to become experts in the development of non- invasive imaging tools, for high and low resource communities, and their use in patients with brain disorders such as depression, traumatic brain injury, and Alzheimer's Disease will advance the ability to provide good medical care. The trainees from this program make significant contributions to medical technologies that enable accurate diagnosis of illnesses and determination of responses to treatments.